APOLLO - Upper Midwest

ABSTRACT
Recipients of a kidney transplant from an African-American deceased donor have worse
outcomes than their counterparts receiving an organ from a White deceased donor. The extent
to which this is due to the presence of high-risk APOL1 genotypes in African-American donors is
unknown. Several recent studies have found a positive association between high-risk APOL1
genotypes and graft failure, but these have been based on relatively few events, have come
primarily from a few large centers, and have not analyzed donor-recipient pairs. The proposed
studies will investigate the association of a kidney donor's APOL1 status with recipient
outcomes. We will also study estimate the impact of APLO1 status on living donor outcomes.
We have assembled a consortium including 6 organ procurement organizations covering 7
states in the Upper Midwest, 123 recovering hospitals, 25 transplant centers and collaborators
in transplant surgery, transplant nephrology, epidemiology and genetics to achieve these goals.
These findings will provide a greater understanding of the impact of the presence of high-risk
APOL1 variants in both recipients and living donors. These data are needed for informed
decision-making for recipients, potential living donors, and their caregivers. Both the relative and
absolute risk of clinically significant events associated with high-risk APOL1 variants will be
estimated with much greater precision that previous studies, allowing more informed decisions
on acceptance of specific organs for transplantation.

Public health relevance
Project Narrative The proposed research is relevant to public health because the results are expected to provide much-needed evidence on which to base decisions regarding donating and accepting kidneys for transplantation. The absolute and relative risks of accepting a kidney from a donor with high-risk variants of APOL1 are needed to allow a potential recipient to make a fully informed decision on whether to accept a donated organ. The impact on recipient outcomes as well as the risks to the donor associated with high-risk APOL1 variants for a living kidney donor are also necessary to make this important decision. Clinicians caring for transplant recipients and donors will use these findings to personalize monitoring and interventions.